Effect of a Crohn’s Disease-associated SLC39A8 Variant on the Small Intestinal Microbiome and Susceptibility to Experimental Models of Enteritis

PROJECT SUMMARY
The primary goal of the UCLA NIH T32 GI Training grant is to continue to train the next generation of
outstanding GI academic thought leaders through postgraduate mentored research training. The T32
program supports 6 trainees/year including Adult and Pediatric GI fellows, General Surgery
residents, and other UCLA post-doctoral trainees. The T32 training period is 2 years except for the
UCLA STAR (Specialized Training in Academic Research) fellows who may be funded for 2 or 3 years
for PhD's completion. In this competing continuation renewal, 6 trainees/year are funded. Another goal
is to train predoctoral medical students for 12 months in a gap year through the Medical Students
Research Training (MSRT) program. Our specific objectives are to: 1) Recruit and train the most
outstanding, committed, and promising trainees as specified above including underrepresented
minorities and women; 2) Support T32 post-graduate training at UCLA including PhD or masters
programs and graduate coursework. 3) Provide mentored research training by dedicated, experienced,
and successful faculty and also career development in individualized structured research programs. We
will accomplish these goals by: 1) Individualizing career development and guidance by the mentors
and other faculty career advisors through personalized advocacy, structuring independent research
projects, and graduate education. 2) Continuing opportunities for rigorous interaction of trainees with
UCLA GI leaders, successful investigators, and visiting professors as well as through enrichment
programs, annual scientific GI research meetings, and research workshops from the UCLA:DDRCC;
UCLA Departments of Medicine, Surgery, Pediatric, Pathology, and Basic Sciences; and the UCLA CTSI.
3) Sustaining a multi-disciplinary administrative T32 leadership structure that has been successful in
supporting and regularly interacting with the faculty and trainees, is highly responsive to trainees'
requests and needs, and has evolved through strategic planning and continuous feedback. The T32
leadership and UCLA program directors also facilitate transition of trainees to junior faculty positions
through career development workshops and by individually advising them. These specific objectives
are implemented by an administrative leadership of four dedicated investigators: the PD/PI
Dennis Jensen, MD who is a clinical investigator, very experienced as the T32 director for 21
years; and three co-Directors - Yvette Taché, PhD (a senior neuro-gastroenterologist and basic
scientist); Joseph Pisegna, MD (a physician-scientist in basic and translational research); and
Martin G. Martin, MD (a pediatric physician-scientist in genetics and basic intestinal luminal
research). There are 34 participating mentoring faculty and a T32 Executive Committee who
provide excellent opportunities for mentored research training, career guidance, and advocacy by
insuring ethical conduct of research and individualized training so that all T32 awardees are successful
as physician- or surgeon scientists and other independent investigators in digestive physiology,
pathology, or GI diseases.

Public health relevance
Project Narrative I could not put the applicant's 6‐page Research Strategy section here. This was limited to only 2‐3 sentences. I have uploaded the Research Strategy section as the second item in “Other Attachments.”